Quantitative characterization of the liver-pancreas axis in diabetes via multiparametric magnetic resonance elastography

PROJECT SUMMARY / ABSTRACT
Nonalcoholic fatty liver disease (NAFLD) is closely associated with the impairment of many metabolic pathways,
including decreased hepatic insulin sensitivity and secretion, increased glucagon, and the risk of developing type 2
diabetes mellitus (T2DM). Conversely, patients with diabetes have a higher prevalence of steatohepatitis and end-
stage liver disease. As an intermediate state of hyperglycemia easily detectable in clinical settings, prediabetes is
the condition that precedes T2DM but the progression is variable, which could increase over time with associated
risk factors. To date, the mechanisms underlying prediabetic progression are still not understood. We think
simultaneous imaging of the abdominal organs’ abnormalities along the liver-pancreas axis and measures of insulin
action, secretion, and hepatic extraction can provide insights into T2DM development, a better understanding of the
relationship between NAFLD and diabetes, and an opportunity to intervene in prediabetic progression.
The overall goal of this work is to develop an advanced multiparametric abdominal MRE method for
characterizing pathophysiologic state of the liver-pancreas axis and prediabetic progression in NAFLD.
• In Aim 1, A multifrequency, self-navigating, and hybrid radial-Cartesian 3D vector magnetic resonance
elastography (MRE) technology will be developed and expanded on the liver, pancreas and fat data acquisition
and image reconstruction. Ten healthy volunteers will be recruited during MRE driver, imaging sequence and
reconstruction development and optimization. Benchmark for technical success will be evaluated with a test-retest
repeatability and measurement agreement study on ten patients with diagnosed NAFLD.
• In Aim 2, We will perform quantitative imaging assessments of the liver-pancreas axis in a cross-sectional study in
150 patients with diagnosed NAFLD with varying risk or progression to diabetes (i.e., 50 patients without diabetes,
50 patients with prediabetes, 50 patients with diabetes). Laboratory and clinical data, as well as insulin secretion
and action measurements, will be collected within 30 days of MRI/MRE. Precursory tissue abnormalities and
integrative metabolic-mechanical models will be trained and evaluated to assess the risk of developing T2DM.
• In Aim 3, assuming 20% withdrawal rate, we plan to have one-year follow-up examinations in 120 patients out of
those who have baseline examinations in Aim 2. The models trained in Aim 2 will be further tuned with longitudinal
MRI/MRE changes for assessing bi-directional treatment effects on tissue composition, structural and metabolic
features, bridging the cellular, gland, enzymes, and hormones to the liver-pancreas axis, thereby predicting
progression or regression direction of diabetes development in NAFLD.
We anticipate that this program will provide initial validation of multiparametric MRI/MRE and the derived
surrogate to assess the liver-pancreas axis of diabetes progression in NAFLD. This project’s success will
also provide a valuable noninvasive assessment tool for emerging therapeutic interventions.

Public health relevance
PROJECT NARRATIVE This research will provide initial validation of multiparametric quantitative imaging and the derived surrogate to assess the liver-pancreas axis of diabetes progression in nonalcoholic fatty liver disease. This proposal will further advance magnetic resonance elastography as a practical imaging tool for qualitatively and quantitatively monitoring pathophysiological states of abdominal organs/glands as it becomes increasingly useful for detecting or characterizing important diffuse disease processes of steatosis, inflammation, and fibrosis, providing capabilities unavailable with other imaging techniques. Imaging-based risk prediction of diabetes development may allow earlier detection, diagnosis, and treatment, ultimately improving health outcomes for the general population.